PERCEPTUAL CONSTRAINTS FOR IMAGE UNDERSTANDING

When one looks at a scene, one is immediately able to classify the edges in the scene, perceiving that this edge is shadow boundary, that edge is a crease in a surface and so on. If we consider the visual system to be working to interpret scene attributes from image data, we would say that th visual system is very good at determining the physical causes of the contours to which edges project in an image. Moreover, the visual system uses information provided by the configuration of contours in an image to help interpret scene attributes such as the shapes of surfaces. The proble of contour interpretation, which includes both of these functions, appears quite difficult when one considers that the information provided in an imag for both functions is locally ambiguous. The approach to the problem adopted by many computer vision researchers is to specify a set of constraints on contour interpretation which, when taken together, define a unique solution. A similar approach can be used to organize research into human perceptual processing of contours. Within the approach, one consider the visual system as implicitly enforcing a set of constraints in its interpretation of contours. The constraints come from two sources; the image data itself and the natura structure of the environment. The present proposal aims to analyze the constraints of both types which are potentially available to the visual system for contour interpretation and to investigate psychophysically the nature of the constraints actually used by the visual system. The research will focus on constraints on two types of contour which have received relatively little attention from vision researchers: reflectance contours, which project from discontinuities in surface reflectance, and shadow contours, which project from discontinuities in illumination in a scene. Also considered will be occluding edges, due to their importance in determining scene structure. An important aspect of the research will be the use of 3D rendering techniques to generate naturalistic images for experimental stimuli. This will allow the manipulation of independent variables in both the 3D scene domain and the 2D image domain. The ability to control the 3D structure of scenes is necessary for the investigation of what natural constraints on edge structure are assumed by the visual system since these are specified in the scene domain, not in the image domain. Th results of the investigation will provide a deeper understanding of the information available in images for contour interpretation and the ways in which this information is used by the human visual system. More broadly, the research relates to the issue of how much knowledge of environmental structure and of the image formation process is incorporated into visual system processing.